Signaling Mechanisms of TMEM16a Regulation

The TMEM16a gene encodes for a Ca2+-activated Cl- channel that is broadly expressed in eukaryotes and
plays an important role in human health and disease. TMEM16a channels are required for numerous
physiologic processes, including regulation of neuronal and cardiac excitability, uterine contractility,
regulation of electrolyte balance, and sensory transduction. Their importance is evidenced by the embryonic
lethality of TMEM16a knockout mice, and by the association of mutations in this channel with craniofacial
cancers. Aside from their Ca2+-dependent activation, it is not understood how these channels are regulated.
Our lab is interested in uncovering the signaling mechanisms that modulate the activity of TMEM16a
channels. Our goal is to understand the primary TMEM16a regulatory pathways, and to facilitate the
development of novel therapeutic options for treating disorders caused by TMEM16a deficiencies.
1

Public health relevance
The proposed research is focused on studying molecular interactions regulating the Ca2+-activated Cl- channel TMEM16a, which mediates various physiologic processes ranging from regulating blood flow through the cardiovascular system to the excitability of neurons. The goal of this research is to uncover the mechanisms of how a lipid called PIP2, regulates channel activity. It is relevant to public health because understanding how these molecular interactions are disrupted in disease will enable better therapeutic design for the wide array of pathologies associated with TMEM16a channels.